NINDS Communications and Outreach Interim Contract

To continue the OCPL needs in Communications Guidance and Strategic Planning, Partnership Development, Public Education Program Development, and Media Relations, Writing Support, Digital Communications, and Material Development